Minority and Minority Serving Institution Faculty in the Field of Cancer Research

Abstract
The American Association for Cancer Research (AACR) requests renewal of support for the project
entitled, “MSI Faculty in the Field of Cancer Research.” The funds for this project will provide support
for the participation of full-time minority faculty and faculty from Minority-serving Institutions (MSIs)
[Historically Black Colleges & Universities (HBCUs), Hispanic Serving institutions (HSIs), Alaska Native and
Native Hawaiian Serving Institutions, Tribal Colleges and Universities (TCUs), and other relevant
institutions] in high-caliber national scientific conferences organized by the AACR. The AACR Annual
Meeting exposes faculty (primarily junior faculty at the level of Assistant Professor) to the broad range
of ongoing cancer research in basic, translational, and clinical areas, and AACR Special Conferences,
allows them to participate in those scientific sessions that are especially relevant to their research
interests and professional growth. Overall, AACR conferences present unique opportunities to interact
with the world’s leading experts and discus the latest findings in rapidly developing areas of cancer
research.
This project is an essential component of a multi-level program instituted by the AACR to address the
problem of underrepresentation of minorities working in cancer research and biomedical science. The
broad objective of the project is to increase the scientific knowledge base of faculty scholars and to
encourage them and their students to pursue careers in cancer research. The project aims to facilitate
faculty scholars’ professional relationships and networking and sponsorship possibilities with national
and international cancer researchers, and to further their careers and enhance their recognition by
professional peers through providing the opportunity to present and discuss their own research findings
before international audiences.
These awards have been generously supported through this R13 funding mechanism from 1997-2021.
The AACR is deeply appreciative to the National Cancer Institute (NCI) for 24 years of supporting
minority faculty scholars and faculty scholars at MSIs in cancer research, their research programs, and
by extension, to the next generation of minority cancer researchers they train in the laboratory and in
the classroom. With the generous support of the NCI, the AACR can assure that it remains innovative
and essential to the future of cancer research.

Public health relevance
Public Health This project is a pivotal initiative by the American Association for Cancer Research since racial and ethnic minorities remain underrepresented as faculty in the field of cancer research. It is imperative to continue to increase the diversity and visibility of faculty members in the field. One of the most important aims of this award program is to facilitate networking and collaboration opportunities for minority faculty and faculty at Minority-Serving Institutions with the wide range of cancer researchers throughout the world. This is not just a necessity for minority faculty, but also essential for faculty at minority-serving institutions. Beyond the direct benefits to Scholar Awardees, the program has potentially wider implications for the health status of the minority population in general, resulting from the formation of a larger pool of experienced minority basic cancer researchers and clinicians to contribute, thrive, and gain health equity in the field. The enhancement of the MSI faculty member’s research program enriches the experience of the minority students he or she trains. Additionally, minority investigators are more likely to explore the issues relating to minority health disparities, as well as to have a better prospect of recruiting and collaborating with minority study subjects, and a significant increase in the number and visibility of minority cancer researchers might serve as an effective antidote to attitudes of distrust on the part of study participants and help lead to greater trust on the part of minorities in the medical and research institutions.